Preclinical assessment of a novel compound for treating radiation-induced oral mucositis

Project Summary
Inflammation and ulceration of mucosal tissue, called mucositis, is a severe side effect of many common
treatments in oncology, including chemo- and radiotherapy. Mucositis development is costly to the health care
system and can lead to poorer outcomes for patients. Mucositis of the mouth and esophagus, called oral
mucositis, is particularly common in head and neck cancer patients receiving radiation therapy, where roughly
80% of patients develop this side effect. Treating oral mucositis remains a large clinical unmet need with no FDA
approved treatments. Using Sinopia Biosciences’ computational platform, we identified a target class and an
associated small molecule for preventing and/or treating mucositis. The target class has an established safety
profile in patients with solid tumors. In two studies with the acute radiation-induced hamster model of oral
mucositis, we observed compelling results that oral administration of the compound significantly decreased the
duration of ulcerative mucositis and in some animals completely prevented the development of ulcers. The
observed effect size was as large or larger than other compounds currently in the clinic tested in the same model.
The test compound is a pan-inhibitor of several targets in the target class, each with multiple binding domains.
In Phase I, we identified the specific domain within this target class that most safely contributes to mucositis
amelioration. Selective inhibition of this domain retains the efficacy of the pan-inhibitor, but avoids the general
toxicity issues seen with pan-inhibition. In this Phase II proposal, we will develop a novel orally bioavailable
compound that selectively inhibits this specific target domain. We will then characterize this new compound in
the fractionated radiation model of oral mucositis mucositis to advance the program towards the clinic.

Public health relevance
Project Narrative Inflammation of the mouth and esophagus, called oral mucositis, is a common and severe side- effect of chemo- and radiation therapy used in cancer treatment that has significant implications on outcomes and health care costs. Sinopia Biosciences has identified a target that shows efficacy in reducing both the duration and severity of oral mucositis in an established model. This proposal will develop a novel compound for that target for oral mucositis.